Targeted radiation and immunocytokine therapy for CEA positive malignancies

SUMMARY/ABSTRACT
Image guided radiotherapy (IGRT) or systemically administered radionuclide therapy are attractive approaches
that can perturb the tumor microenvironment (TME) so that targeted immunotherapy can convert a largely
immunoresistant into an immunosusceptible tumor. Although this approach has been clinically explored using
high or low or high plus low dose IGRT plus untargeted checkpoint immunotherapy, further improvements are
warranted and require testing in appropriate clinical studies and preclinical models. In this application we
propose three aims to test our hypothesis that IGRT and or targeted alpha therapy (TAT) followed immediately
by immunocytokine (ICK), a form of targeted immunotherapy, will lead to increased tumor infiltration of IFN+
CD8s (Teff) and decreased Foxp3+ CD4s (Treg). This hypothesis is supported by two studies targeting CEA,
a major marker of solid tumor malignancies (eg. colon and breast), in CEA transgenic mice that are
immunocompetent, express CEA in normal tissues, and are tolerant to CEA. We now propose to test this
hypothesis in two clinical trials, aims 1 (IGRT + ICK) and 2 (TAT), and perform immunocorrelate studies for
Teff and Treg cells, among others, on pre- and post-therapy biopsies. Aim 2 is a TAT only study as a prelude
to a third clinical trial combining TAT plus ICK, that will be initiated at the end of the project period. In aim 3, we
will refine our animal studies to determine TME changes immediately after sequential therapy for both IGRT
plus ICK or TAT plus ICK, by a combination of PET imaging for CEA, CD8s and stromal cells by fibroblast
activated protein (FAPI), along with flow and IHC analysis of tumors, LNs and spleen. We expect the results of
aims 1 and 2 to further guide aim 3, and the results of aim 3 to guide future trials that incorporate IGRT and/or
TAT plus ICK in CEA positive malignancies.

Public health relevance
PROJECT NARRATIVE Sequential therapy of solid tumors with tumor targeted radiation therapy followed by untargeted immune therapy has shown promise in the clinic. This approach can be further improved by using targeted immune therapy and studying the immune response on tumor biopsies taken before and after therapy. Using a combination of clinical and animal model data, we will refine the therapeutic doses and identify the best predictive markers of response to therapy.